SLEEP NEED IN YOUNG &AGED

This project aims at demonstrating that the new OSU Chronobiology Lab is able to carry out temporal isolation experiments in human subjects; develop ambulatory monitoring techniques for monitoring long-term sleep regulation in old and young subjects; add to existing evidence of low spontaneous sleep rates in aged subjects.